Strengthening Addiction Care Continuum through Community Consortium in Vietnam

Abstract
The current opioid epidemic calls for global attention. Opioid use disorder is a chronical condition that
requires long-term comprehensive health services, from assessment, treatment, continuous monitoring, to
extended care. Medication-assisted therapy, although available as an effective strategy to treat opioid
addiction, has been significantly underutilized due to the hard-to-reach nature of people who use opioids
(PWUO) and the shortage of addiction specialist. An impetus for expanding and enhancing addiction treatment
is to mobilize community-based healthcare agencies and family members of PWUO. The study will take
advantage of the existing community health care infrastructure and family support systems in Vietnam to
develop and test an intervention to strengthen a continuum of addiction services. The intervention, entitled
“Community Care Consortium (CCC),” features community health workers’ joint effort with family members to
provide patient-centered, individualized addiction care and support. The intervention will be developed and
tested through three phases in three regions of Vietnam (Ninh Binh, Da Nang, and Can Tho). In Phase 1, we
will conduct formative studies with community health workers, community representatives, PWUO, and their
family members to identify barriers to addiction service utilization and discuss potential strategies to establish a
continuum of addiction services. Based on the formative study findings, the CCC intervention and its
implementation plans will be developed through workgroup meetings with researchers, community members,
and target users. In Phase 2, the CCC Intervention will be piloted in three communes and revised based on
acceptability/feasibility data, process evaluation, and feedback from field staff and participants. In Phase 3, a
randomized controlled trial of the CCC Intervention will be conducted in 60 communes, which will be
randomized to either an intervention condition or a control condition (30 in each condition). A total of 720
PWUO, 720 of their family members, and 180 commune health workers (CHW) will participate in the study.
The intervention outcomes on PWUO, CHW, and family members will be assessed with the data collected at
baseline, 3-, 6-, 9- and 12-month follow-ups.

Public health relevance
Project Narrative The significant gaps in people who use opioids (PWUO)’s care seeking, testing, treatment, and retention are impeding efforts to address the current opioid epidemic. This study aims to mobilize community health workers and PWUO’s family members to support a continuum of addiction services in Vietnam. Study findings are expected to demonstrate a model of community-based addiction service continuum that can be transferable to other countries, including the U.S.